SUBTHRESHOLD OPIOID USE DISORDER PREVENTION TRIAL (CTN-0101). DSC5 CONTRACT. 09/20/2019 - 11/16/2020. N01DA-19-2250.

SUBTHRESHOLD OPIOID USE DISORDER PREVENTION TRIAL (CTN-0101).

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.